Evidence to Impact: Accelerating Implementation of Aging Research

ABSTRACT
Expected increases in the number of older adults, in general with more complex health needs, creates both
challenges and opportunities for health care systems and services to optimize health and well-being. While the
demand on primary care and the continuum of health services changes with age, the need for evidence-based
interventions that respond to the needs of older adults becomes even more apparent. However, the process of
translating evidence to practice is neither automatic nor easy, even when supported by strong evidence. It is
estimated that only 14% of a population receives an intervention even 17 years after efficacy is established.
Targeted activities that integrate researchers, clinicians, healthcare administrators and stakeholders are
needed to accelerate evidence adoption. Even among areas with evidence adoption, significant opportunities
remain in aging research to increase attention to implementation at scale (Stage V of the NIH Stage Model).
Leveraging a partnership across NIA centers and a strong collaboration between Duke and Wake Forest
Universities, we are proposing a conference series to identify, problem solve and address real-world barriers to
research translation. Generating collaboration and engagement opportunities across NIA centers and
investigators could facilitate health system adoption of interventions with new evidence or established
interventions with limited scale. Emphasis is also needed on implementation or de-implementation of
interventions, policies and practices with wide disparities and under- or overuse. Our aims are to (1) engage
researchers to identify and help disseminate interventions for older adults in health care settings with evidence
to maintain or restore independence that have yet to be adopted or reach equitable implementation to scale;
(2) explore innovative and pragmatic strategies to optimize implementation in new collaborative teams; and (3)
provide an annual aging research and health care conference that intersects the application of scientific
methodologies of implementation, improvement and learning health system sciences with health care service
delivery, payment and policy. Our commitment to equity and diversity will help integrate individuals from
different perspectives to bring renewed energy and creativity to overcome gaps in knowledge, therapeutic
inertia, and processes for change. To improve accessibility of the meeting, this series will be held as a pre-
conference to the Claude D. Pepper Older Americans Independence Centers (OAIC) Coordinating Center
annual meeting and be facilitated with options for virtual or telephonic remote participation. Our goal—to
stimulate new research-clinical-administrative partnerships that accelerate evidence to impact and advance
healthcare equity—aligns with several of NIA’s strategic directions as we focus on implementation (and de-
implementation) of interventions to improve older adults’ health, well-being and independence and reduce
health disparities.

Public health relevance
PUBLIC HEALTH RELEVANCE A persistent trend exists in the science of health care interventions for older adults; some of what we know works does not get provided in everyday routine health care and some interventions that have no benefit continue to be offered and delivered. In this conference series we will increase awareness of the evidence translation gap; we will use specific case studies in multidisciplinary teams to examine the barriers to implementing research and scaling it broadly, or de-implementing interventions that may be harmful or ineffective. Each conference brings together national leaders, key stakeholders, and promising junior and experienced scientists. The goal is to stimulate new collaborations for implementation research that ultimately improves health and independence in old age.